A mGlu2/3 agonist in the treatment of PTSD

The glutamatergic system plays a role in certain common behavioral manifestations of posttraumatic stress disorder (PTSD), e.g. mechanisms of fear learning and anxious arousal. We propose to evaluate the efficacy of the mGlu2/3 receptor agonist pomaglumetad methionil in treating PTSD in a randomized, double-blind, placebo-controlled, phase II clinical trial. Key endpoints of this trial include structured diagnostic and self- report measures of PTSD and related symptomatology, as well as objective biomarkers of fear acquisition and expression. Evaluation of the differential efficacy of the mGlu2/3 agonist pomaglumetad methionil on symptom clusters that comprise the theory-driven and empirically-supported five-factor phenotypic model of PTSD symptoms will provide greater specificity regarding how this drug differentially modulates unique dimensions of the PTSD phenotype. Given the inhibitory effects of mGlu2/3 receptor agonists on stress-induced NE secretion, we predict that pomaglumetad methionil will have the most pronounced effect in mitigating anxious arousal symptoms.!

Public health relevance
This proposal aims to determine the role of the mGlu2/3 agonist pomaglumetad methionil in the treatment of posttraumatic stress disorder (PTSD). We propose to recruit patients with PTSD, and will conduct a placebo- controlled, double-blind, randomized clinical trial. Key endpoints of this trial include structured diagnostic and self-report measures of PTSD and related symptomatology, as well as objective biomarkers of fear acquisition and expression.